IKKalpha, autophagy, obesity and injury enhanced pancreatic cancer

DESCRIPTION (provided by applicant): Pancreatic cancer (PanCa) ranks eighth worldwide and fourth in the US as a cause of cancer deaths and is one of the most lethal cancers. New therapeutic and preventive approaches to PanCa should take into consideration the targeting of precursor lesions, intraepithelial neoplasia (PanIN), intraductal papillary mucinous neoplasm (IPMN) and mucinous cystic neoplasm (MCN), that precede invasive pancreatic ductal adenocarcinoma (PDAC), which is refractory to most currently available drugs. Although intrinsic genetic changes associated with formation of precursor lesions and their progression to PDAC are relatively well defined, the molecular mechanisms by which external factors increase PanCa risk are unknown. Major PanCa risk factors are old age, tobacco smoking, obesity, diabetes and chronic pancreatitis. It is also not clear if and how these risk factors accelerate progression of precursor lesions, which may be dormant for many years, to invasive PDAC. We have now developed two models based on targeted deletion of IκB kinase a (IKKα) in pancreatic epithelial cells (PEC) that allow investigation of mechanisms through which risk factors, such as obesity and pancreatitis, affect development of PanIN lesions and their progression into fully invasive PDAC. Mice lacking only one Ikkα allele in PEC are phenotypically normal, but when placed on high fat diet (HFD) develop metaplastic PanIN lesions within four months. However, the homozygous deletion of Ikkα in PEC (IkkαΔpan mice) results in spontaneous development of pancreatic fibrosis and pancreatitis in mice kept on low fat diet. When IkkαΔpan mice are made to express a KrasG12D oncogene in PEC, they rapidly and frequently develop highly invasive PDAC at a time when wildtype mice with activated KrasG12D in PEC mainly exhibit PanIN lesions. Preliminary studies indicate that the earliest pathological changes in IkkαΔpan mice are impaired autophagy, accumulation of the ubiquitin binding chaperone p62 and ER stress. IKKα downregulation and p62 accumulation were also observed in human pancreatitis, PanINs and PDAC. We therefore suspect that these changes may play an important role in PanCa pathogenesis. Accordingly, we will determine: 1) how IKKα controls autophagy and ER stress in pancreatic acinar cells; 2) the contributions of defective autophagy to the development of pancreatic fibrosis and accelerated malignant progression; 3) whether ER stress contributes to accelerated progression of PanCa in IkkαΔpan mice; 4) the role of p62 accumulation in enhanced tumorigenesis in IkkαΔpan mice; 5) how haploinsufficiency for IKKa results in PanIN lesion development upon HFD consumption and whether prolonged obesity causes eventual PanCa development in Ikkα+/Δpan mice in the absence of an activated Kras transgene. The completion of these studies will result in a much better understanding of the molecular etiology of PanCa and may lead to new strategies for blocking the progression of precursor lesions to invasive PDAC.

Public health relevance
We will study, using a new mouse model we have developed, how consumption of high fat diet leads to formation of precursor lesions that give rise to pancreatic cancer. We will also study the molecular and cellular mechanisms that control the progression of these lesions to fully malignant and currently incurable pancreatic cancer.